Secondary Histologic Analysis of TUS Studies

Project Abstract
The nucleus accumbens (NAc) is a target for non-invasive brain stimulation for the treatment of substance use
disorders (SUDs). Due to its location deep in the brain, transcranial ultrasound stimulation (TUS) is unique
among non-invasive brain stimulation methods to be able to focus on the NAc with high spatial resolution.
TUS has been shown to be effective in animal models, without any evidence of damage from either behavioral
studies, H&E stained sections, or TUNEL staining. Further, there have been millions of diagnostic imaging
studies at the pressures proposed for TUS, that have appeared to be safe. As a result, it is currently under
active investigation in humans.
However, when it comes to safety, we are compelled to examine all existing data. In particular, we have
existing data from our prior studies in which we applied TUS to the sheep brain and examined it on H&E
stained sections, as well as TUNEL staining. Here in this proposal, we seek to extend this analysis to the
examination of inflammatory cytokines and the examination of glial cells using immunohistochemistry. These
studies will give us a more complete picture whether TUS has an inflammatory effect on the brain.

Public health relevance
Project Narrative Completely noninvasive neuromodulation using transcranial ultrasound stimulation (TUS) offers the promise of precisely stimulating specific targets deep in the brain, such as the nucleus accumbens for substance abuse disorders, at low power levels commonly used for diagnostic imaging studies. It is currently under active investigation in humans. However, when it comes to safety, we are compelled to examine all existing data. In particular, we seek to extend a prior analysis of TUS to the sheep brain to the examination of inflammatory cytokines and the examination of glial cells using immunohistochemistry.